Discovery Proteomics Core

The Discovery Proteomics Core (DPC) uses cutting edge and robust sample preparation, state-of-the-art
proteomic and complementary biophysical, and lipidomics technologies to analyze adaptive changes in
neuronal signal transduction mechanisms that occur in response to drugs of abuse. Aim 1 uses Data
Dependent Acquisition (DDA) and Data-Independent Acquisition (DIA) to identify proteins whose expression or
posttranslational modifications (PTMs) are altered in cell-based systems, tissue from discrete brain regions,
single cell types and their organelles isolated with LCM, FACS, FANS or single cell dispensing. We will
continue to build project specific spectral libraries to support DIA assays as well as implement library-free
searches. Aim 2 uses immunological and chemical approaches to enrich for peptides and proteins containing
PTMs to facilitate their identification. In collaboration with TPC, the DPC will integrate PTM analyses into DIA,
including use of FAIMS based data acquisition for glycosylation and “Middle-down” analyses, and use Parallel
Reaction Monitoring by the TPC to validate differentially expressed proteins and PTMs. Aim 3 uses “Middle-
down” analyses to identify the multiple PTMs that occur in individual proteoforms such as the combinatorial
epigenetic changes in histone modification. In Aim 4 we will use new tools and databases to improve analysis
and interpretation of large scale, quantitative MS/proteomics data sets. To improve peptide identification from
searching databases with MS/MS spectra, we will implement a CHIMERYS search mechanism for DDA and
DIA data; and we will collaborate with the Biostatistics and Bioinformatics Core to enable MS/MS searches of
RNA-sequencing-predicted proteomes. In Aim 5 we will purify recombinant proteins and exosomes from
plasma or cell culture media for our investigators and use Nanoparticle Tracking Analysis, Dynamic Light
Scattering, and Asymmetric Flow Field-Flow-Fractionation coupled with Multiangle Static Light Scattering to
characterize size distribution and to fractionate the purified exosomes. In Aim 6 we will monitor localization and
metabolism of phosphoinositide lipids, a major class of signaling lipids, in brain circuits involved in addiction
and provide methodology for studying the role of intracellular protein-mediated lipid transport in the control of
these circuits. In Aim 7, we will provide training in experimental design, sample preparation, and use of
software for analysis and interpretation of MS data, biophysical, and phosphoinositide analyses. The DPC will
ensure that the Center's research is supported by the most advanced instrumentation and biotechnologies. By
taking a holistic approach the DPC will provide Center investigators with the broad range of tools and training
needed to identify, and then to understand why certain proteins and their PTMs and phosphoinositide effectors
are differentially expressed following exposure to drugs of abuse.